Methods for characterizing mechanobiology of the tumor microenvironment landscape

Cells within the tissue microenvironment sense, process and respond to mechanical cues from their
environment. This mechanosensing is essential for tissue homeostasis, and its dysregulation drives tumor
development, growth, and metastasis. Therefore, characterizing its mechanobiology – the interplay between
mechanical cell-microenvironment interaction and cell signaling – can play an important role in helping (a) cancer
biologists gain mechanistic insights for developing improved drug treatments for cancer; and (b) provide
pathologists and clinicians the ability to help develop improved markers for predicting risk of cancer development
and relapse, its metastatic potential, and response to therapy in individual patients. However, despite its
importance in both preclinical and clinical settings no computational methods currently exist to readily incorporate
mechanobiological properties of tissue microenvironments in cancer research and its translation. To overcome
this gap in our knowledge, we aim to develop a novel algorithm that combines high-resolution Hematoxylin and
Eosin (H&E) digital pathology (DP) imaging and highly multiplexed immunofluorescence (HxIF) microscopy with
physical optics-based principles of light-matter interaction to characterize mechanobiology properties of three-
dimensional tumor microenvironments (TME) across whole slide tissue sections at sub-cellular resolution. In our
published work we have shown that light-matter interaction can capture structural alterations with nanoscale
sensitivity within the specimen. Here, we hypothesize that computationally implementing this principle on tumor
microenvironments imaged using DP and HxIF microscopy can quantitatively capture intrinsic
mechanobiological properties of the cellular and acellular components of the microenvironment that go beyond
image analysis and machine learning based feature extraction. Combining this computational imaging method
with information theoretic principles we also aim to provide researchers with the ability to quantify the major
cellular interactions driving these mechanical properties. We note that in many scenarios – for example, in
pathology – it is not possible to access tissue samples at a temporal resolution that faithfully captures the
complexity of an evolving tumor. Therefore, the ability of our method to capture interaction from a single tissue
microenvironment will be very valuable for pathologists to better predict future outcomes. It will also be very
useful for cancer and developmental biologists using animal models and organoids to study mechanisms driving
cell fate decisions. We aim to develop our algorithm with successful completion of two aims. (1) Computational
imaging algorithm for mechanobiological characterization of 3D microenvironment. (2) Information theory-based
algorithm for characterizing directed mechanobiological interactions. By providing mechanobiological
characterization of TMEs for the first time, our methods will have multifactorial impact on understanding the
spatial systems biology of TMEs from development of new mechanobiology based diagnostic, prognostic, and
surveillance biomarkers to new targets for overcoming mechanobiology mediated patient resistance to therapy.

Public health relevance
A novel computational imaging algorithm that combines principles of light matter interaction and information theory to characterize the mechanobiology of three-dimensional whole slide tumor microenvironments, which is important for understanding cancer development, its metastasis and its response to therapy. The input to the algorithm is Hematoxylin and Eosin brightfield images capturing the tissue structure, and multiplexed immunofluorescence images spatially profiling the molecules and cellular diversity of interest.